New Approaches to Dementia Heterogeneity

ABSTRACT
The University of California San Francisco Alzheimer’s Disease Research Center (UCSF ADRC) is a major
catalyst for a broad spectrum of research in Alzheimer’s Disease and Related Dementias (AD/ADRD) conducted
at UCSF and has served as a cornerstone for national and international multi-site diagnostic and treatment
studies. In four previous cycles of funding, we have organized a critical mass of AD/ADRD research and share
our resources widely. The central theme of the ADRC is “heterogeneity in dementia,” with a focus on young-
onset and atypical presentations of AD/ADRD in diverse populations. We excel in clinical phenotyping, imaging,
biospecimen analysis, and pathologic characterization of large and unique cohorts of early-onset and atypical
AD, frontotemporal dementia (FTD) spectrum, Traumatic Encephalopathy Syndrome (TES)/Chronic Traumatic
Encephalopathy (CTE), Creutzfeldt-Jakob disease (CJD) and functionally intact controls. The ADRC supports
and effectively leverages additional NIH and foundation funding, philanthropy, and industry collaborations to
accomplish its aims. In the past cycle, ADRC resources were utilized by 47 R grants, 18 K awards, six U grants,
two T grants, six non-federal training grants and 59 clinical and industry sponsored trials. In this P30 renewal
application, we accelerate efforts to define subtypes of healthy aging, mild cognitive and behavioral impairments
(MCI/MBI), AD, TES, FTD spectrum and prion diseases, improve early recognition and tracking of transitions
from normal aging to dementia, and stimulate drug development and clinical trials. The ADRC will consist of
seven cores: Administrative, Clinical, Data Management and Statistics (DMS), Pathology, Outreach Recruitment
and Engagement (ORE), Imaging, and Biomarker and a Research Education Component (REC). These cores
will work to pursue the following overarching Specific Aims: Aim 1: Explore the features of brain aging, MCI/MBI,
AD, FTD-spectrum disorders, TES/CTE and CJD to better understand their clinical, genetic, pathological, and
molecular underpinnings via data collected in the Clinical, Path, Biomarker, and Imaging Cores. Aim 2: Promote
innovative research on early and accurate diagnosis, novel treatments, and future prevention of heterogeneous
AD/ADRD by sharing data, images and biosamples from our unique clinical cohorts with local investigators, the
ADRC network (via NACC, SCAN and NCRAD) and the broad research community. Aim 3: Recruit Chinese
Americans, Latino Americans and Black/African Americans to the Clinical Core and offer education to these
communities through the ORE Core. Aim 4: Develop innovative approaches to data management and
biostatistics in the DMS Core to support easy access and analysis of ADRC-related data, while offering statistical
support to our investigators. Aim 5: Train new leaders in research via the REC and educate community
professionals and laypeople through the ORE Core using approaches that highlight the heterogeneity of
AD/ADRD. Aim 6: Enhance diverse perspectives via alliance with local and national organizations, engagement
with community advisory boards, and promotion of diverse and multi-disciplinary ADRC faculty and staff.

Public health relevance
PROJECT NARRATIVE The UCSF Alzheimer’s Disease Research Center (ADRC) will benefit public health by advancing knowledge about brain conditions that cause cognitive decline and dementia. The ADRC collects data about medical and neurological conditions, cognitive test performance, DNA and blood samples, brain images and autopsy. These data are shared with other researchers to advance science on aging and dementia.